Tumor-associated pDC (TApDC) in liver cancer with HIV infection

The long-term goals are to study functions of tumor-associated plasmacytoid dendritic cells (TApDC) in tumor
immune microenvironment (TIME) of liver cancer or hepatocellular carcinoma (HCC) during HIV infection and
immunotherapy, and to develop novel therapeutics to treat HCC in HIV-infected patients, which has a
disproportionate impact on African American and African/Asian immigrant communities. Current combination
antiretroviral therapy (cART) has increased life span for people with HIV (PWH). However, PWH patients
experience accelerated immunological aging (inflammaging) which is characterized by up-regulation of
inflammatory cytokines, immune dysfunction, and end-organ diseases such as liver cancer/HCC. One major
recent advancement in liver cancer immunotherapy is to use combined immune checkpoint inhibitors (ICI) CTLA-
4 and PD-1 (PD-L1) blocking antibodies to elevate anti-tumor immunity. Current anti-CTLA-4 antibodies used
clinically exhibit suboptimal cancer immunotherapeutic effect (ITE), but they also lead to serious immunotherapy-
related adverse events (irAE). Our preliminary results show that i) pDC depletion in hu-mice with HIV infection
and effective cART rescued anti-HIV CD8+ T cells to control HIV-1 persistence in HIV-infected humanized mice.
ii) pDC depletion resolved inflammation-related tissue injury, reversed immune exhaustion and restored activity
in CD8+ T cells, including TCF1+ PD1+ TIM3- stem-like CD8 T cells in number and functions. iii) In NSG-based
humanized immune/tumor model (HCC-HIT mice), human tumors grew faster than in NSG mice, associated with
abundant tumor-associated pDC (TApDC), elevated TA-Treg and exhausted (TCF1-PD1-TIM3+) T cells, but
reduced stem-like CD8 T cells. iv) Depletion of TApDC in human HCC-HIT mice reduced HCC growth and
rescued stem-like CD8 T cells in number and functions, associated with depletion of TA-Treg. We hypothesis
that TApDC in HCC TIME are further elevated by HIV/cART and contributes to both immune suppression in
promoting liver cancer and to irAE during ICI immunotherapy of HCC. Depletion of TApDC during ICI therapy
may i) lead to depletion of TA-Treg and ii) rescue stem-like CD8 T cells that respond to PD-1 ICI. We propose
the following specific aims to test the idea. Specific Aim 1 will study how TApDC reprogram HCC TIME in HCC-
HIT mice +/- HIV. We will also define how HIV infection affects TApDC/TIME in HCC-HIT mice and characterize
human TApDC after HCC induction +/- HIV infection. TApDC depletion affects human HCC growth in HCC-HIT
mice +/- HIV infection and how Specific Aim 2 will define how TApDC modulates anti-tumor specific T cells and
enhance CITE of PD1 ICIs in mice. We hypothesize that depletion of TApDC in combination with PD1 mAb will
enhance its CITE by reducing Treg and increasing stem-like CD8 T cells that respond to anti-PD1 mAb. Aim 3
will investigate how TApDC interact with ICIs to modulate CITE and irAE in HCC-HIT mice+HIV. We postulate
that depletion of TApDC in HCC will not only enhance PD1 ICI-associated CITE but also mitigate its irAE in HCC-
HIT mice. Key findings will be confirmed in future clinical studies in HCC patients with and without HIV infection.

Public health relevance
The goals are to study functions of tumor-associated plasmacytoid dendritic cells (TApDC) in human liver cancer during HIV infection and immunotherapy, and to develop novel therapeutics to treat liver cancer in HIV-infected patients. Key findings will be confirmed in future clinical studies, including clinical trials, in liver cancer patients with and without HIV infection.